Early T cell responses in tuberculosis

PROJECT SUMMARY
Tuberculosis (TB) remains the deadliest infectious disease worldwide, causing more than 1.5 million deaths per
year. The causative bacteria, Mycobacterium tuberculosis (Mtb), is a slow growing intracellular pathogen that
predominantly affects the lungs. BCG, an attenuated strain of Mycobacterium bovis, is the only vaccine in use
and offers limited protection against pulmonary TB and protection that wanes through adolescence. To make
progress in new vaccine development, we need a better understanding of the immune responses to Mtb in
relevant model systems. Notably, contributions of unconventional T cells (CD1-restricted, MR1-restricted, and
gd T cells) to containment of acute Mtb infection are not well understood. In this proposal, I outline a
characterization of these niche T cell subsets using a non-human primate model of Mtb infection. Non-human
primates recapitulate the disease states observed in humans, have immune systems that mirror humans, and
can be challenged with a low dose of Mtb. This work is therefore critical for building on transgenic rodent studies
and contextualizing human peripheral blood analysis that has limited correlation with lung granulomas. Our
results will inform vaccine design using unconventional antigen classes. The first aim of this project will
characterize the frequency and functionality of these populations in early granulomas relative to uninvolved lung
tissue. Based on prior work in our group, 4 weeks is the earliest that lesions can be grossly identified and isolated.
PET CT guided necropsies enable excision of individual granulomas for immunological analyses.
Unconventional T cell populations will be identified using loaded tetramers and antibodies targeting conserved
TCR regions. In the second aim, I will use T cells isolated from bronchoalveolar lavages (BAL) before and after
Mtb challenge and lung tissue excised at necropsy to perform FucoID, a method of identifying T cells that
recognize Mtb infected macrophages. This will demonstrate the abundance of Mtb-reactive T cells and, in
combination with tetramer staining, the expansion of unconventional subsets following infection. In Aim 3, I will
use sections of uninvolved lung lobes to develop an ex vivo granuloma organoid model. The lung sections will
be incubated with Mtb and tracked over time to monitor the formation of cellular aggregates and early granuloma
structures. This model will provide the TB field with a tool to study early disease dynamics without the prohibitive
cost and facility requirements for in vivo experiments, while also enabling analysis at earlier timepoints (i.e. days)
post-inoculation than can be feasibly done using in vivo systems. This work directly addresses open questions
in the field of TB immunology, including the presence, localization and functions of unconventional T cells in
acute TB, which will guide antigen selection and platforms in future vaccine development. The aims provide
experimental and analytical training prospects via existing collaborations as I become an independent
investigator. This work will be performed at the University of Pittsburgh, where I have access to ABSL-3 facilities,
with mentorship from Dr. JoAnne Flynn, a leading expert in TB and NHP immunology and Dr. Philana Ling Lin,
a pediatric ID physician and expert in NHP models of SIV/TB co-infection.

Public health relevance
PROJECT NARRATIVE Tuberculosis continues to be one of the leading causes of death from an infectious agent worldwide while being largely forgotten in western nations. The advent of the antibiotic era, in combination with widespread acceptance of the live attenuated BCG vaccine, diverted attention and associated funding towards therapeutics that are often logistically impractical for various socioeconomic reasons in TB endemic areas. While it is widely acknowledged that the best chance of ending endemic transmission in high-risk communities is a vaccine, new candidate formulations employing traditional peptide antigens continue to fail in NHP studies or clinical trials after showing modest promise via in vitro or rodent models. Successful vaccine design requires a comprehensive understanding of immunological responses associated with Mtb infection. Here I propose to study how unconventional T cell responses may contribute to vaccine induced protection, with the goal of improving vaccines against TB.